TRANSFECTION OF CDNAS FOR DRUG METABOLIZING ENZYMES

Retroviral vectors have been used to transfer and express cyclooxygenase (COX) 1and 2. 10T1/2 and AS52 cells that stably express high levels of retroviral vector transferred murine COX-1 or -2 were developed and characterized. The expressed COX-2 preferentially utilized specific endogenous AA (arachidonic acid) pools (i.e., TPA released but not Ca ionophore released AA). Furthermore, NO (nitric oxide) was shown to enhance both COX-1 and -2 activities. The TPA and NO findings may be relevant to the COX's hypothesized role in carcinogenesis and inflammation. Additionally, we showed that COX-1 and -2 metabolically activated 1,1-dimethylhydrazine, aflatoxin B1, and N-acetylbenzidine to mutagens. Furthermore, the cells were useful in identifying NSAIDs which were selective for COX-1 and COX-2.